Investigating histone glycation as a new dynamic epigenetic mark

Project Summary
The past decade has witnessed explosive advances in our understanding of how the organization of
chromatin controls gene expression in eukaryotes. Much of the work delineating these mechanisms has
contributed to the notion that a so-called ‘Histone Code,’ which refers to the landscape of histone post-
translational modifications (PTMs), is a central determinant of a gene's potential to be activated or
repressed in response to environmental stimuli. However, although detected in vivo, very little is known
about how non-enzymatic covalent modifications (NECMs), such as glycation, affect the established
cellular transcriptional program. We recently found that glycation, which is the hallmark of diabetes,
accumulates on histones in a disease state-dependent manner (Zheng et al. Nature Communications,
2019). Using a variety of biophysical, biochemical and genetic methods we found that histone glycation
disrupts regulatory histone PTMs as well as changes chromatin architecture in vitro and in cells by forming
both histone-histone and histone-DNA crosslinks. Importantly, we identified a cellular regulatory response
to this damage in the form of the deglycase DJ-1 as well as more recently, an arginine-specific deglycase,
PAD4, which further demonstrates the crosstalk between histone glycation and other enzymatic PTMs
(Zheng et al., in revision). In this proposal, we will take an interdisciplinary approach and leverage new
chemical probes we developed to determine the sites of glycation on histones and their distribution within
chromatin. In addition, we will perform a high-resolution analysis to identify the precise mechanistic effect
histone glycation has on higher-order chromatin structure and the epigenetic landscape. Finally, we will
investigate the cellular response to glycation by identifying “readers” and “erasers” of this new mark.
Successful completion of this project is expected to yield a detailed molecular mechanism linking a new
class of histone modifications to transcription regulation, thus providing essential insights into a
fundamental biological problem and opening the door to new therapeutic avenues.

Public health relevance
Project Narrative Diabetes is the fastest growing epidemic in the western world and is characterized by high levels of blood sugar, which reacts non-enzymatically with cellular proteins in a process called glycation. We recently found that glycation specifically accumulates on histones, inducing significant changes in chromatin architecture and subsequent cellular transcription. The proposed research project will comprehensively examine the molecular mechanisms of histone glycation, elucidate its contribution to abrogated chromatin structure and function, and finally characterize repair mechanisms that will open new avenues for therapeutic development in both diabetes and cancer.